Targeting a Ceramide Double Bond to Treat Cardiometabolic Disorders

Project Summary
Overnutrition and physical inactivity promote the accumulation of sphingolipids such as ceramides which block
insulin signaling and anabolic metabolism. Implementation of pharmacological or genetic interventions to block
ceramide synthesis in rodents prevents or reverses an impressive array of metabolic pathologies (e.g. insulin
resistance, diabetes, steatohepatitis, hypertension, cardiomyopathy, and atherosclerosis). Herein we aim to
evaluate the therapeutic potential of inhibiting dihydroceramide desaturase-1 (DES1), our preferred target in the
ceramide synthesis pathway, in the treatment of insulin resistance and non-alcoholic fatty liver disease. Aims
will involve the following:
1. Evaluating the consequences of inhibiting DES1 on metabolic disorders in mice
2. Determining the mechanism by which the subtle molecular changes to ceramides caused by DES1
inhibition alter cellular function
Findings obtained from these studies could lead to new pharmacological approaches for treating diabetes and
other cardiometabolic diseases.

Public health relevance
Narrative Ceramides are fat metabolites that accumulate in individuals susceptible to diabetes and heart disease. Blocking their production in rodents improves both conditions. Herein we aim to investigate the potential of therapeutics that inhibit dihydroceramide desaturase-1, an enzyme required for ceramide biosynthesis, in the treatment of diabetes and heart disease.